Core A - Administrative Core

PROJECT SUMMARY/ABSTRACT
Core A will provide administrative oversight for the P01. Its responsibilities will fall into several areas, some
purely administrative and some related to the exchange and archiving of reagents and scientific
information. Given the geographic separation between the two participating institutions, frequent
videoconferences will be held. Core A will schedule them and archive their content. Core A will also coordinate
the shipments of DNA samples, cryopreserved sperm, and live mice between institutions, which is critical to the
research in Core B, Project 1, and Project 2. Core A will arrange for the archiving of sperm with the appropriate
MMRRC branch repositories. Core A will oversee the collection and maintenance of P01-related data within
relational databases maintained on Mutagenetix (http://mutagenetix.utsouthwestern.edu). Quality records of
experiments and production will be required of all personnel associated with the P01. On the administrative side,
Core A will be responsible for tracking the financial status of the P01; assuring compliance with all regulatory
bodies at UT Southwestern and Institut Necker-Enfants Malades; the sharing of resources and models and their
distribution, either directly or via repositories; all transfer of physical materials and intellectual property on behalf
of the P01; and the resolution of problems in management or the implementation of any aspect of the scientific
or administrative goals of the P01. Core A will assist in the preparation of progress reports as required by NIH,
and with the preparation of publications, both in conventional journals and via the web.